CYTOKINE LEVELS/CARDIOPULMONARY BYPASS FOR REPAIR OF CHD

The purpose of this study is to identify the pattern of elaboration of cytokines in patients placed on CPB for repair of CHD. The cytokines that have been measured include: Tumor Necrosis Factor, interleukins 6 and 8 (IL-6 and IL-8).